The DNA Packaging Motor of Bacteriophage phi29

7. Project Summary/Abstract The mechanism of DNA packaging for double-stranded DNA viruses will be studied in the Bacillus subtilis bacteriophage φ29, the most efficient in vitro viral packaging system known. Using an integrated genetic, biochemical and structural approach, we will characterize protein conformational change and movement in the transiently assembled packaging motor during DNA encapsidation. The mechanism of packaging in φ29 will serve as a model for animal virus packaging in the analogous herpesvirus and adenovirus systems, and aid in the search for new antiviral therapies. Due to similarities between the φ29 ATPase and other ring translocases, insights gained from the study of φ29 packaging will also provide insight into the basic principles of macromolecular motor function in higher organisms. To interrogate the mechanism of DNA packaging we will: determine and validate the atomic structure of the fully assembled φ29 packaging motor complex using X-ray crystallography and cryoEM analysis (Aim 1); elucidate the mechanisms of force generation and intersubunit coordination during DNA translocation in a complex motor using integrated structural, genetic and biochemical approaches (Aim 2); and characterize the molecular events that culminate in termination of packaging using mutagenesis and biochemical analysis and cryoEM analysis (Aim 3).

Public health relevance
8. Project Narrative The assembly and movement of macromolecules in biological systems drive all aspects of health and disease at the cellular level. Study of the structure, assembly and function of the bacterial virus φ29 DNA packaging motor serves as a model for understanding these fundamental biological principles and can inform us about similar processes in higher organisms. The DNA packaging process of φ29 will also serve as a model for understanding similar events in the medically relevant herpesviruses and adenoviruses, thus providing targets for the development of new antiviral therapies.